The interplay of the CST complex and telomerase at human telomeres

Project Summary/Abstract
This proposal is a companion to R35CA210036, which is focused on the role of telomeres in cancer with three
areas of particular emphasis: 1. The molecular mechanism underlying the telomere tumor suppressor pathway;
2. The genome instability caused by telomere dysfunction in cancer development; and 3. The opportunity to use
telomere biology to gain deeper insights into 53BP1-mediated DSB repair. This R50 requests salary support for
Dr. Hiroyuki Takai, who is a highly productive long-term Research Specialist in the Unit Director’s laboratory.
Dr. Takai has been a key member of the Unit Director’s laboratory since 2002. His main interest in
genome instability in cancer started with his studies of the Chk1 and Chk2 effector kinases of the ATR and ATM
DNA damage signaling pathways, respectively. In the de Lange lab, Dr. Takai discovered that the stable
expression of the ATR and ATM kinases as well as all other PI3K-related kinases requires Tel2, which he showed
acts as a chaperonin (Takai et al. Cell 2007). In a second breakthrough, Dr. Takai was the first to demonstrate
that cells detect dysfunctional telomeres as Double-strand Breaks (DSBs), activating the ATM kinase and
accumulating DNA damage response factors at chromosome ends. Dr. Takai’s method for detecting telomere
damage has become the standard assay the field (Takai et al. Curr. Biol 2003) and his findings explained the
role of telomere shortening in cancer. Prior to the activation of telomerase, telomere attrition imposes a
proliferative barrier during early cancer development when critically short telomeres activate the DNA damage
response and induce senescence or apoptosis. More recently, Dr. Takai has focused on the molecular
mechanism of the telomere shortening. Telomere shortening derives in part from the inability of DNA replication
to copy the ends of linear DNAs. However, the greatest factor in telomere attrition is the 5’ resection of telomere
ends after their replication, a process needed to generate the protective 3’ telomeric overhangs. After this
process, excessive 5’ end resection at telomeres is counteracted by Pola/Primase mediated fill-in synthesis (Wu,
Takai, and de Lange, Cell 2012). Dr. Takai showed that Pola/primase is recruited to telomeres through the
interaction of its accessory factor, CST, with the telomeric shelterin complex. Dr. Takai next showed that in
absence of CST/Pola/primase, unmitigated resection leads to stochastic shortening of the 5’ ended strand and
telomere loss (Takai et al. GenesDev 2016). Finally, Dr. Takai was instrumental in a study from the Unit Director’s
laboratory establishing an analogous role for CST/Pola/primase in the repair of DSBs (Zirman et al. Nature
2018). A long-term member of the Unit Director’s group and a highly-skilled, rigorous, creative, and collaborative
scientist, Dr. Takai is a pivotal contributor to the R35 research program. Dr. Takai is highly committed to the Unit
Director’s research on the role of telomeres in cancer and his career goal is to continue to excel and support the
success of the R35 through innovative and path-breaking research.

Public health relevance
Project Narrative The shortening of human telomeres represents a tumor suppressor pathway that is by-passed by the activation of telomerase in cancer. This project focuses on the molecular mechanism of telomere shortening and the role of the CST complex in this process. The experiments will contribute fundamental knowledge on telomere maintenance and the role of telomeres in cancer.